ALZHEIMER CAREGIVER COPING--MENTAL AND PHYSICAL HEALTH

Compare physiological reactivity of vulnerable and nonvulnerable caregivers to experimental stressor probes. Administer non-specific and specific probes to access cardiovascular reactivity. Compare vulnerable and nonvulnerable caregivers on measures of beta receptor sensitivity and density. Changes in cellular adhesion molecules that are related to platelet aggregation, with the risk of stroke, will also be measured.